Tulane Essentials in Internal Medicine Symposium

The practice of internal medicine and its subspecialities is constantly evolving. Emerging research regularly redefines and modifies standards in clinical practice to improve patient care. As advances in internal medicine continue to progress rapidly, internists, subspecialists, and allied health professionals must remain abreast of the latest discoveries in human health and disease, including the newest diagnostic and treatment tools and approaches, to ensure they develop the optimal treatment plan for each patient. The goal of the Tulane University Essentials in Internal Medicine Symposium is to disseminate the most up-to-date findings and practices across our local healthcare workforce, allowing clinicians to improve outcomes in healthcare, research, quality of life, and public health for our region’s patient population. Organized annually by a team of physicians and physician-scientists from a range of subspecialties, the Essentials in Internal Medicine Symposium brings together physicians, fellows, residents, medical students, and allied health professionals from across the New Orleans metropolitan area. New Orleans has a high prevalence of chronic health conditions, including cardiovascular disease, stroke, and obesity. With a regionally focused participant base, this event allows New Orleans’ health professionals to learn from and network with peers who treat the same populations and navigate the same local and cultural challenges. The meeting is organized into a series of thematic lectures presented by world-class experts in the latest developments in internal medicine, designed to encourage dialogue and innovation. Relevant to the National Heart, Lung, and Blood Institute, the majority of topics center around the cardiovascular and pulmonary systems; these include lipid management, aortic stenosis, tricuspid regurgitation, hypertension, artificial intelligence applications for clinical cardiology, and smoking cessation. Additional sessions are dedicated to cancer, gastroenterology, and palliative care.

Public health relevance
As advances in internal medicine continue to progress rapidly, internists, subspecialists, and allied health professionals must remain informed of the latest discoveries in human health and disease, including the newest diagnostic and treatment tools and approaches, to ensure they develop the optimal treatment plan for each patient. The goal of the Tulane University Essentials in Internal Medicine Symposium is to disseminate the most up-to-date findings and practices across our local healthcare workforce, allowing clinicians to improve outcomes in healthcare, research, quality of life, and public health for our region’s patient population. This initiative aligns well with the mission of the National Heart, Lung, and Blood Institute “to promote the prevention and treatment of heart, lung, and blood disorders and enhance the health of all individuals so that they can live longer and more fulfilling lives.”